Developmental Research Program (DRP)

Project Summary/Abstract
The Developmental Research Program (DRP) is an integral part of the UCSF Brain Tumor SPORE and
represents the best opportunity to explore new ideas as pilot projects, to develop new resources, to apply new
technologies to translational brain tumor research, and to promote collaborations among scientists at UCSF
and outside institutions. In this manner the DRP ultimately serves as a means to build and support new
technologies, to support the early stage development of projects that can compete successfully for peer-
reviewed funding, and, in the best case scenario, for inclusion as full projects in the SPORE Program.
The Specific Aims of the UCSF Brain Tumor SPORE DRP are:
1. To implement new technologies and resources for translational brain tumor research
2. To help develop collaborations among scientists within UCSF and at different institutions
3. To develop new ideas as pilot projects to replace SPORE projects or generate other funding

Public health relevance
Project Narrative The Developmental Research Program is required component of all SPOREs and must be maintained for the entire funding period. Funds provided by the UCSF Brain Tumor SPORE, supplemented by funds provided by the UCSF Department of Neurological Surgery through the Helen Diller Family Comprehensive Cancer Center (HDFCCC), allow the SPORE to provide $50,000 direct costs for up to three DRP projects per year.